Using ultrasound and microbubbles to augment antibiotic efficacy against periprosthetic joint infections

Project Summary/Abstract
In the >1,000,000 joint arthroplasties performed annually in the United States, ~5% will experience
periprosthetic joint infection (PJI), with a 5 year mortality rate above 11%, (exceeding that of breast cancer,
melanoma, and Hodgkin’s lymphoma). To prevent PJI, surgeons maintain stringent sterility in the operating
theater, initiate prophylactic intravenous (IV) antibiotics at least 1 hour prior to surgery, ensure joint sterility with
antiseptic lavage, and, depending on the center, may place 1-2 g of powdered vancomycin in the wound during
closure. Bacterial survival and the ensuing potential for infection are attributed to formation of implant-adherent
bacterial biofilms. These antibiotic-tolerant bacterial aggregates are formed by bacteria most commonly
responsible for PJI, including Staphylococcus aureus (S. aureus), methicillin-resistant S. aureus (MRSA), and
Staphylococcus epidermidis (S. epidermidis). Once PJI is present, the surgeon may attempt a “debridement with
antibiotics and implant retention” (DAIR) procedure, which currently has an ~50% re-infection rate in the United
States. Otherwise, a one- or two stage exchange revision arthroplasty, which relies on implant removal, local
antibiotic treatment and re-implantation, is undertaken; these have an ~25% re-infection rate. We hypothesize
that failure of the infection treatment is at least partially caused by the continued presence of the floating and
tissue-adherent bacterial aggregates. To that end, we have shown that bacterial aggregates can be sensitized
to antibiotics in vitro and in vivo using a combination of antibiotics and ultrasound-triggered microbubble
destruction (UTMD). In this application, we propose that an adjunct treatment of local antibiotics + UTMD
will increase antibiotic efficacy in the joint space, thus lowering infection recurrence rates compared to
clinical standard of care of surgery and antibiotics alone. We will investigate this adjunct therapy for each
of the two main surgical treatments for PJI, in forty-eight (48) patients undergoing the DAIR procedure and in
forty-eight (48) patients undergoing a one- or two-stage exchange arthroplasty revision for infection. The primary
outcome of the study will be to compare time to reinfection between the experimental group (n = 24) and the
control group receiving clinical standard of care (n = 24) for both procedures. In addition, as part of the insonation,
we will develop quantitative ultrasound (i.e., H-scan) for prediction of infection-associated bone changes to
determine any correlation with chronic PJI. We aim to determine the efficacy of this adjunct therapy, and to
develop an immediately clinically-adaptable therapy to tackle the significant challenge of PJI. We expect that the
combination of local antibiotics and UTMD will be broadly applicable to preventing surgical site infections, and
ultimately decrease the incidence of PJI in primary and revision arthroplasty.

Public health relevance
Project Narrative Infections in patients receiving total knee joint replacements, also known as arthroplasty, are devastating, and often result in chronic pain and long-term antibiotic use to mitigate symptoms. We aim to augment clinical attempts to treat joint infections and prevent re-infection by using ultrasound and microbubbles in the joint following revision surgery to enhance antibiotic activity. We also expect that this technique can be applied to other joint sites, as well as initial arthroplasties, to help prevent chronic infections for millions of patients.